A comprehensive device integrating fentanyl test strips with sample preparation features for convenient and discreet fentanyl testing in high-risk environments

Project Summary
The opioid crisis, fueled by fentanyl contamination, has escalated, with fentanyl involved in nearly 70%
of overdose deaths in the U.S. in the past year [1-5]. This crisis stems from cheaply produced fentanyl being
mixed into illegal drugs, including counterfeit pills. In 2022, the DEA found that 6 out of 10 fake prescription
pills contained a potentially lethal dose offentanyl [16]. Fentanyl test strips (FTS) are an effective detection tool
but are often difficult to use, especially in public or social settings. The current multi-step testing process is
time-consuming and error-prone, discouraging use and increasing overdose risks [11]. This strains healthcare
systems and impacts broader societal issues like productivity and crime rates. Recent research shows that
people who inject drugs (PWID) with a positive FTS result were five times more likely to change their drug use
behavior [13]. However, those who used FTS after drug consumption were 70% less likely to modify
subsequent behavior, highlighting the need for a more accessible and user-friendly testing method.
To address these challenges, TeaSun is developing a streamlined fentanyl testing device that enhances
accessibility, speed, and ease of use. Our innovation integrates multiple testing steps-crushing, measuring,
and assaying-into a single, convenient unit, setting it apart from existing solutions. This all-in-one approach
significantly simplifies the testing process, making it more practical for use in urgent or public situations. By
incorporating FTS directly into the device, we aim to improve their accessibility. We plan to reach this market
through strategic partnerships with U.S. harm reduction organizations, which spend $460 million annually on
harm reduction supplies. Our team, which includes experts in product development, harm reduction, and drug
testing, is well-positioned to execute this plan.
Our innovation combines several testing steps into a single device, protected by U.S. patent
11478788B1. The design also incorporates human-centered design principles and is informed by Social
Cognitive Theory, which emphasizes peer influence in behavior change. By creating a device that can easily
be adopted and shared among social networks, we expect to foster trust and widespread adoption.
In Phase I, Specific Aim 1 will focus on developing the technical feasibility of the device by designing
and building a prototype, ensuring ease of use with three-step, one-handed operation with accurate measuring.
Following the development of the prototype, Specific Aim 2 will focus on commercial feasibility and usability.
We will conduct focus groups with key stakeholders, including people who use drugs and harm reduction
professionals, to assess the device's ease of use, comfort, and practicality. Feedback from these sessions will
drive iterative refinements to the design, improving its user-friendliness. Specific Aim 3 will focus on scientific
feasibility, testing the device's detection limit, sensitivity, and specificity using real-world samples. Overall, our
project aims to develop a convenient drug checking device to improve FTS accessibility in high-risk settings.

Public health relevance
Project Narrative: We propose to develop a user-friendly tool to streamline the multi-step process using fentanyl test strips to simplify the drug checking process in volatile, high-pressure environments such as public social settings or when users' capacities are compromised. With a potential market size of $297.3 million annually, we will efficiently reach opioid-naive young adults aged 18-35 who use psychostimulants (e.g., MDMA, cocaine, methamphetamine) and are at risk of overdose in volatile, high-pressure social gatherings by leveraging partnerships with harm reduction organizations. Our team consists of experts in product management, drug testing, and harm reduction, and is well-positioned to execute this plan in a capital-efficient way, addressing a critical public health need with strong exit potential.